Adding CTSI-CN COVID Data to the N3C

PROJECT SUMMARY This proposal requests a supplement to the parent NCATS award for the Clinical and Translational Science Institute at Children’s National (CTSI-CN), a partnership with George Washington University. The supplement is requested to aid our CTSI-CN informatics team and clinical investigators extract targeted data from the electronic health records of patients who have been tested for SARS-CoV-2 as part of the COVID-19 pandemic at either of our two institutional hospital systems, namely, Children’s National Hospital and George Washington University Hospital. These data will then be deposited with the National COVID Cohort Collaborative (N3C) data enclave. We will then develop an approach for regular data transfers to keep the N3C data enclave up to date with important data from Washington DC from across the health lifespan.

Public health relevance
PROJECT NARRATIVE This proposal will facilitate the transfer and regular updates of COVID-19 de-identified clinical data from Children’s National Hospital and George Washington University Hospital into the National COVID Cohort Collaborative (N3C) for use by researchers across the country as part of the N3C data enclave.